The role of antigen-independent T cell activation in controlling M. tuberculosis infection

SUMMARY
Tuberculosis (TB) is caused by the bacteria Mycobacterium tuberculosis (M.tb) and was responsible for 1.6
million deaths in 2021. The only licensed TB vaccine, the Bacillus Calmette-Guérin (BCG) vaccine, protects
infants and children from disseminated disease but provides only partial protection in adult pulmonary disease.
T cells are known to be critical in the host response to M.tb infection, but the mechanisms of this protection are
not fully understood and further research is needed to develop new, effective vaccines. The first category of T
cells are classical T cells that recognize peptide antigens presented by major histocompatibility (MHC) molecules
and include two subsets, helper T cells that express the CD4 coreceptor (CD4 T cells) and cytotoxic T cells that
express a CD8 coreceptor (CD8 T cells). The second category are nonclassical T cells that recognize non-
peptide antigens via MHC independent mechanisms and consist of several distinct subsets. Two subsets of
nonclassical T cells are CD1a/b/c restricted T cells and T cells that express a CD8 coreceptor (CD8 T
cells). CD1a/b/c T cells recognize mycobacterial lipids presented by CD1a, CD1b, and CD1c molecules and
have exhibited antimicrobial effector functions in response to M.tb infection. In contrast, the role of CD8 T
cells in M.tb immunity is unknown. Antigen independent activation of T cells, termed bystander activation, occurs
via proinflammatory cytokines and has been observed to have a protective effect in cancer and
infection. Specifically in M.tb infection, bystander activation of noncognate memory T cells has shown a host
protective impact by decreasing bacterial burden. CD8 T cells have exhibited higher levels of bystander
activation compared to their CD8 classical counterparts. In contrast, the ability of CD1a/b/c restricted T cells
to undergo bystander activation is unknown. Thus, CD1a/b/c restricted T cells are implicated in M.tb immunity,
but their susceptibility to bystander activation has not been explored. Conversely, CD8 T cells are known to
undergo bystander activation but their role in M.tb infection has not been established. In Aim 1, we will determine
the ability of CD1a/b/c restricted T cells to undergo bystander activation, explore the underlying signaling
mechanisms of this activation, and evaluate the ability of bystander activation to induce anti-bacterial effector
programs during M.tb infection. In Aim 2, we will define the role of bystander activated CD8 T cells in M.tb
infection, defining the antigen-independent functions of the subset on granuloma formation and bacterial control.
Our proposal aims to fill the corresponding gaps in knowledge of the role of bystander activated CD1a/b/c
restricted T cells and CD8 T cells during M.tb infection. In addition to potentially illuminating a novel pathway
to target for M.tb vaccines, these studies will more comprehensively analyze T cell activation in M.tb immunity.

Public health relevance
PROJECT NARRATIVE Our lack of understanding of the mechanisms of T cell mediated protection against Tuberculosis, a disease responsible for 1.6 million deaths in 2021, has hampered our ability to develop new vaccine strategies. Antigen- independent T cell activation, termed bystander activation, has shown protective effects in response to M.tb infection but has not been fully explored or characterized. Here, we will comprehensively analyze the role of bystander activation in two T cell subsets in the context of M.tb infection to extensively explore this protective pathway as a possible vaccine target.